Molecular mechanisms underlying heme transport at the blood-brain barrier and its role in angiogenesis

PROJECT SUMMARY
This application details career development and research plans that have been uniquely tailored to facilitate
transition of the principal investigator, Dr. Rosemary J. Cater, to an independent academic position. Dr. Cater
has a multidisciplinary background, and through this K99/R00 proposal, seeks to finalize her biochemical
training, master the biology of a new system, and gain skills for her career as an independent investigator.
The K99 phase of this award (first two years) involves a structured career development plan that will allow Dr.
Cater to: advance her skills in single particle cryo-electron microscopy (cryo-EM); gain essential training in brain
endothelial cell-based assays and proximity-based labeling experiments; and acquire important career skills
such as grant writing, science communication, laboratory management, teaching, responsible conduct of
research, and mastery of the academic job application process. The career development plan also includes clear
and actionable steps for identifying and successfully obtaining an independent tenure-track faculty position by
the end of the K99 phase. Dr. Cater has assembled a top-tier team of multi-disciplinary mentors, advisors, and
collaborators that will oversee and guide her training, research program, and transition to independence.
The research plan proposed spans both the mentored (K99) and independent (R00) phases of the award. It
involves mechanistic studies of the heme transporter FLVCR2, which is expressed within blood-brain barrier
endothelial cells and plays a key role in the development of brain vasculature. The research program for the K99
phase aims to characterize the structure and function of FLVCR2 at a molecular level. The R00 research program
then aims to delineate how FLVCR2 regulates angiogenesis at a cellular level. Core research questions
addressed include: What are the molecular determinants important for FLVCR2 to bind heme specifically? What
conformational changes must FLVCR2 undertake to transport heme? What drives this transport process? And
ultimately, how is FLVCR2-mediated heme transport linked to cerebral angiogenesis?
To answer these questions, Dr. Cater has formed a comprehensive research plan combining structural biology,
biophysics, membrane protein biochemistry, electrophysiology, and cellular biology. It involves cryo-EM structure
determination of FLVCR2; functional characterization of FLVCR2 using liposome-based assays and
electrophysiology; interrogation of the link between FLVCR2 and angiogenesis using brain endothelial cell-based
assays; and mapping the FLVCR2 interactome using proximity-based labeling assays. This research will provide
key insights into how FLVCR2 transports heme in brain endothelial cells and this in turn regulates angiogenesis.
The proposed studies for the K99 phase will largely take place at Columbia University, which is home to a vibrant
and collegial community of structural biologists, biophysicists, and biochemists. This environment is ideal to
facilitate Dr. Cater in the successful completion of the proposed K99 research program and achieving her goal
of transitioning into a successful independent researcher.

Public health relevance
PROJECT NARRATIVE Blood vessels in the brain serve two critical functions: supplying the brain with important nutrients and protecting it from toxins. This research will reveal the molecular mechanisms underlying how the important signaling molecule called heme regulates the formation and growth of blood vessels in the brain. These findings will provide a deeper understanding of diseases associated with compromised cerebral blood vessel integrity, such as stroke and hydrocephalus, and have the potential to aid delivery of drugs to the brain – an ongoing bottleneck in neurotherapeutic development.